STUDY OF PERIPHERAL NOREPINEPHRINE STORE IN PHEOCHROMOCYTOMA

The ratio of plasma dehydroxyphenyl glycol to norepinephrine (NE) levels will indicate whether or not exaggerated neuronal release of NE occurs in patients with pheochromocytoma.